Improving sleep in gynecologic cancer survivors

PROJECT SUMMARY
Sleep disturbance is one of the primary complaints of gynecologic cancer survivors, with more than 80% of
survivors reporting sleep difficulties. Sleep disturbance also contributes to worsened health-related quality of
life (HRQOL) and increased symptom burden. Although non-pharmacological interventions for sleep
disturbance have been explored among cancer populations, up to 50% of survivors do not adhere to treatment
recommendations, possibly due to the behaviorally labor-intensive nature thereof. Therefore, there is a need
for more effective and acceptable approaches to improve sleep outcomes in cancer. This application proposes
a career development plan to support Dr. Rina Fox in establishing an independent research program focused
on examining strategies to improve HRQOL and reduce symptom burden among cancer survivors, with
particular consideration for the role of sleep and circadian rhythms in the overall disease experience. Her
career development will be supported by a multidisciplinary group of researchers. Her mentors, Drs. Ong, Rini,
and Zee, are recognized scholars in behavioral sleep medicine, cancer control and survivorship, and circadian
rhythms and biology, respectively. They have lengthy histories of federal funding, multidisciplinary
collaboration, and successful mentorship of trainees who go on to achieve independence. Dr. Fox’s training will
be enhanced by expert consultants who will provide guidance in clinical gynecologic oncology (Dr. Tanner),
biostatistics and optimization methodology (Dr. Siddique), qualitative research methods (Dr. Kaiser), circadian
activity rhythms and execution of sleep-focused research among cancer survivors (Dr. Ancoli-Israel), and
biobehavioral mechanisms of intervention efficacy and psychosocial intervention development specifically
among gynecologic cancer survivors (Dr. Penedo). The aim of this application is to optimize a behavioral
intervention to decrease sleep disturbance (primary outcome), and improve HRQOL and reduce symptom
burden (secondary outcomes) among gynecologic cancer survivors. In Phase I, 15 participants will
simultaneously receive three candidate intervention components known to reduce sleep disturbance (i.e., sleep
restriction, stimulus control, and bright light), and will subsequently complete semi-structured individual
interviews to provide feedback regarding barriers and facilitators to intervention adherence. In Phase II, 80
participants will be randomized to evaluate these intervention components within a 23 full factorial trial design,
as guided by the Multiphase Optimization Strategy (MOST) framework, to identify the optimal combination of
candidate intervention components, enhanced to promote adherence, that best affect the study’s primary and
secondary outcomes. Sleep disturbance and circadian markers will also be evaluated as potential mechanisms
underlying the candidate intervention components’ effects on study outcomes. Results of this innovative
research will directly lead to an R01 application and an independent and programmatic line of research for Dr.
Fox focused on HRQOL, symptom burden, and sleep and circadian disturbance among cancer survivors.

Public health relevance
PROJECT NARRATIVE Sleep disturbance is a prominent concern among gynecologic cancer survivors with severe and negative implications for health-related quality of life (HRQOL); however, leading non-pharmacologic sleep interventions often do not maximally benefit this population, possibly due to high treatment burden. The proposed study will identify barriers and facilitators of treatment adherence, and optimize a behavioral intervention to diminish sleep disturbance, increase HRQOL, and reduce symptom burden among gynecologic cancer survivors. This study will yield an improved treatment package to address the prevalent and impactful concern of sleep disturbance among gynecologic cancer survivors.